Project 2-Identifying and exploiting metabolic vulnerabilities in PDAC

Project 2 -­ Abstract/Summary

Our mechanistic work has established general principles of metabolic reprogramming in PDAC, revealing
therapeutic insights that show dramatic effects in preclinical models (alanine metabolism blockade) as well as
benefit in the clinic (autophagy inhibition). In this next cycle, we seek to address two key questions to enable us
to most effectively define and exploit metabolic vulnerabilities in PDAC. First, how do the different concurrent
cancer gene mutations that define PDAC subsets influence cancer cell metabolism and the metabolic interplay
with the TME? Secondly, what role does regulation of mitochondria, organelles central to integration of
metabolism and innate immune signals, play in metabolic reprogramming and cancer-­stroma cell interactions in
genetic subsets of Kras* PDAC? By developing a series of novel GEM models and patient-­derived KRAS* PDAC
models representing major genotypes, we have identified pronounced genetically-­driven differences in tumor
cell metabolism and cancer-­immune cell interactions. We hypothesize that cooperating genetic alterations drive
distinct metabolic programs and associated vulnerabilities in cancer cells. Moreover, we predict that immune
differences will further influence cancer cell metabolism in these distinct genetic settings. To address these
hypotheses, we propose the following aims: #1 Determine the influence of major PDAC gene mutations on
metabolic programs;? #2 Assess role of the autophagy/lysosome system on tumor-­TME crosstalk in genetic
subsets of PDAC;? and, #3 Investigate mitochondrial regulation and relationship to metabolism and inflammatory
signaling in PDAC subsets.

Public health relevance
Project 2- Narrative During the previous funding cycle, our work established general principles for metabolic reprogramming in PDAC, revealing therapeutic insights that show benefit in the clinic and dramatic effects in preclinical models. In this next cycle, we will address the role of mitochondria and various concurrent gene mutations in influencing cancer cell metabolism and its interplay with the tumor microenvironment. Understanding these key roles will enable us to most effectively exploit metabolic vulnerabilities of PDAC and lead to effective therapeutic development for patients.